DETERMINATION OF STRUCTURE OF HIGH AFFINITY IGE RECEPTOR FROM MAST CELLS

We have produced crystals of the extracellular domain of the high affinity IgE receptor from mast cells. This receptor provides a crucial link between soluble antibody and cell-based mechanisms of immunity. The receptor-IgE interaction is the key molecular recognition step associated with immediate-type hypersensitivities such as allergic and anaphylactic shock reactions. The crystals diffract weakly on laboratory sources and we are requesting time to collect high resolution data at SSRL.